INTRANASAL PEPTIDE T IN THE TREATMENT OF PERIPHERAL NEUROPATHY OF AIDS

The purpose of this study is to examine the effects of Peptide T on symptoms of painful neuropathy associated with HIV infection.